Development and preliminary examination of two brief personalized feedback interventions focused on lab-based and EMA alcohol cues to reduce hazardous young adult alcohol use

PROJECT SUMMARY/ABSTRACT
Alcohol misuse and negative consequences remain prevalent among young adults (YAs) (Hingson et al.,
2017; Schulenberg et al., 2018). Meta-analytic findings on the efficacy of brief alcohol interventions suggest
that these effects may not be as strong as previously believed (Huh et al., 2015), highlighting the continuing
need to develop effective interventions to reduce YA alcohol misuse. The parent R34 grant develops and tests
two online personalized feedback interventions (PFIs) that focus on recognizing urges to drink in response to
alcohol cues (e.g., beer bottle) as well as strategies for coping with urges. Alcohol cues evoke subjective
craving and physiological and neural responses among drinkers (Reynolds & Monti, 2014; Schacht et al.,
2013). Cue reactivity has been demonstrated in the natural environment among older adolescent and YA
drinkers. On occasions when alcohol cues are present, YAs report stronger urges to drink, and on days with
stronger urges to drink they report more alcohol consumption (Ramirez & Miranda, 2014). PFIs have not
explicitly targeted cue reactivity, and many YAs may have limited awareness of this phenomenon. A cue-based
PFI may reduce YA alcohol misuse by enhancing YAs’ awareness of their own personal cues that elicit
alcohol-seeking behavior and by equipping YAs with skills for coping with urges. The parent R34 grant
develops two online Cue Reactivity PFIs: (a) a lab-based Cue Reactivity PFI that summarizes cue reactivity
from an in vivo cue reactivity session with exposure to preferred alcoholic beverages, and (b) a Cue Reactivity
PFI that capitalizes on the utility of ecological momentary assessment (EMA) to capture alcohol cues as
experienced in the natural environment. The EMA period includes 17 days of surveys (4x/day) to report cue
exposure, craving, and alcohol outcomes. Both PFIs focus on recognizing alcohol cues, understanding
responses to cues, and acquiring coping skills. In Study 1 (Aim 1), a series of focus groups and interviews
were conducted with YA heavy drinkers (ages 18-24) to refine the procedures and interventions for a pilot
study. Study 2 is a pilot study with a community sample of 200 YA heavy drinkers (ages 18-24) who report
thinking about stopping or reducing their drinking. Participants are randomized to one of four conditions (n = 50
per group): (1) Lab-based Cue Reactivity PFI, (2) Lab-based assessment only control (AOC), (3) EMA-based
Cue Reactivity PFI, or (4) EMA-based AOC. We will examine the feasibility and acceptability of the PFIs (Aim
2A), evaluate PFI effects on craving, drinking, and consequences at 2-week and 3-month follow-ups, relative to
AOC conditions (Aims 2B-C), evaluate Lab-based versus EMA-based PFI effects on drinking outcomes (Aim
2D), and examine condition as a moderator of the association between craving and drinking at follow-up as
well as explore moderators (e.g., biological sex) of intervention effects (Aim 2E). This research has great
potential to inform advancements to personalized feedback interventions targeting YA alcohol use.

Public health relevance
PROJECT NARRATIVE Alcohol use peaks for many individuals in young adulthood (ages 18-24) and is of particular concern given young adults’ increased likelihood of heavy drinking and negative consequences. Personalized feedback interventions can be administered online and are among the most promising and cost-effective interventions for reducing alcohol misuse. In line with NIAAA’s Strategic Plan, the parent R34 project aims to advance intervention strategies for reducing young adult alcohol misuse by developing and testing novel online brief interventions that include personalized feedback on young adults’ cue reactivity.